The Gut Microbiome Brain Axis and Preterm Infants

PROJECT SUMMARY
Infancy is increasingly being recognized as a key time point of microbiome establishment that impacts
neonatal health as well as later outcomes. The intestinal microbiome has specifically been implicated in
neurologic outcomes via the gut-brain axis. However, means by which the intestinal microbiome can have
influence on the brain are poorly understood. The preterm infant is at the nexus of these unknowns. Preterm
infants are a vulnerable patient population at risk for significant poor long-term neurodevelopmental outcomes.
Preterm infant brain development occurs in parallel with intestinal microbiome development, thus modification
of the intestinal microbiome is a potential means of improving neurodevelopmental outcomes. In this proposal,
we will test the hypothesis that distinct gut microbiome taxa and metabolites at key time points improve
preterm infant neurodevelopmental outcomes at school age.
Our preliminary and published data in gnotobiotic mouse models demonstrates that different early
preterm infant microbiota impact neuron number, myelination, and behavior. This proposal will use our ongoing
MIND (Microbiome In Neonatal Development) preterm infant cohort to determine how the gut microbiome
impacts neurodevelopmental potential in the NICU, and how it may alter neurodevelopmental trajectories post-
NICU discharge. We will conduct longitudinal sampling of participant fecal and blood samples to monitor gut
microbiome as well as fecal and serum metabolites. We will also perform neurodevelopmental testing during
the NICU course and up until preschool/school age (3.5-5 years old). School readiness, which describes
children's strengths, challenges, and needs for supports when learning in the classroom, is a functional
outcome that differs from single summary measures of intelligence (IQ) and will be the outcome measure.
A combination of 16S rRNA gene sequencing, metagenomics and metabonomics will be applied to the
collected fecal samples. Sophisticated machine learning strategies will be used to develop novel models of
preterm infant gut microbiome succession with time as a critical element. Serum cytokine analysis and
metabonomics will provide mechanistic insight into how the gut microbiome may be impacting
neurodevelopment. We have established complementary in vivo gnotobiotic mouse models, in which germ-free
mice are transfaunated with preterm infant microbiota. This state-of-the-art experimental model will allow
specific investigation of the impact of clinically relevant microbiota on brain development that is not possible in
human infants. The goal of this proposal is to discover intestinal microbiome patterns associated with school
readiness, identify the key time points that represent windows of opportunity for microbiome optimization, and
identify mechanisms by which the intestinal microbiome impacts brain development and behavior. This new
knowledge will enhance our understanding of the gut-brain axis and lay the foundation for microbial based
therapeutics to improve infant neurodevelopmental trajectories.

Public health relevance
PROJECT NARRATIVE The intestinal microbiome has impact beyond the gut and the existence of a gut-brain axis has been proposed. Preterm infants are at risk for poor neurodevelopmental outcomes. This proposal will study how the changes in bacterial colonization patterns of preterm infants over time from birth until school age impact brain development, and thus school readiness and learning for these vulnerable infants.